Training Grant in Quantitative Sciences for Cancer Research

Summary/Abstract
This is a competing renewal application that requests continued support for providing pre- and post-doctoral
trainees with strong methodological and practical training in quantitative cancer research. The application
leverages a unique combination of strengths from the Harvard T.H. Chan School of Public Health (HCSPH),
Dana-Farber Cancer Institute (DFCI) and Dana-Farber / Harvard Cancer Center. This training program, now in
its 39th year, draws upon a distinguished faculty, consisting of biostatisticians, computational biologists, and
other data scientists, as well as world renowned experts in cancer treatment and research. Its overarching goal
is to provide the trainees with all essential elements of training needed to successfully undertake current
cancer research. The specific goals of this training program are to train students and postdoctoral fellows to
be(1)quantitative scientists in cancer research, who are capable of using probability, statistics, computer
science and mathematics to increase our knowledge and understanding of cancer; (2) strong team
leaders/players as well as excellent communicators in a cancer research environment, who can effectively
disseminate their research results and assume active roles in the design, analysis and interpretation of cancer
clinical trials, cancer population studies and cancer genomic studies. All predoctoral students supported by this
training grant are required to take a cognate concentration in cancer-related courses. During their first and
second summer periods in the program, students are required to participate in research activities, typically
performed under the supervision of faculty mentors affiliated with the program. Afterwards, many of these
students will take up residence at the DFCI or elsewhere at DFHCC and continue their research in cancer,
which eventually evolves into their dissertation projects. All the postdoctoral fellows are closely involved with
the practice of quantitative sciences in cancer and are typically in residence at the DFCI. All trainees are
required to actively participate in the a working group seminar series on quantitative issues in cancer research,
which serves as a primary forum at Harvard to discuss current issues and challenges on this topic, as well as
in several of the DFHCC sponsored symposia and event. This proposal requests 5 years of funding to support
10 pre-doctoral students and 1 post-doctoral fellow annually.

Public health relevance
Narrative This program trains pre- and post-doctoral quantitative researchers to conceive and conduct cutting-edge methodological and collaborative research in cancer clinical trials, computational biology, cancer genomics, cancer epidemiology and population science. The program also teaches them to become strong team leaders/members, and to be excellent communicators in a cancer research environment, to effectively disseminate research results, and to assume active roles in the design, analysis and interpretation of cancer research projects including cancer genomic studies, cancer clinical trials, and cancer prevention trials.